Instrumentation and Services Core

INSTRUMENTATION AND SERVICES CORE
Project Summary/Abstract
The goal of the MS INBRE Instrumentation and Services Core (ISC) is to enable research in the fields of
multiomics (genomics, proteomics, and metabolomics/lipidomics), gene-editing, cellular assays, and imaging.
The Core will continue to serve as a nucleus for the development of research and educational programs aimed
at increasing the competitiveness of extramural research funding across MS through implementation of
advanced technologies to answer important biomedical questions. During the previous funding period, the ISC
had a major impact on supporting the MS INBRE and other MS researchers that overall involved 1,197
projects, more than 64,000 samples, and culminated in 376 abstracts/presentations, 200 peer-reviewed
publications, and submission of 222 extramural grants. The ISC is committed to enhancing and maintaining
state-of-art instrumentation and initiating and coordinating the use of research technologies for basic and
clinical research initiatives in the state of Mississippi. To accomplish this mission, it will provide exemplary
technical expertise in the field of multiomics, cellular assays, and cutting-edge imaging technology to
Mississippi investigators with a focus on researchers at undergraduate institutions. ISC will operate with the
goal of offering timely, high-quality data and analyses at competitive costs, and provide opportunities to
educate and train students, faculty, and staff at academic institutions that would not have the independent
resources to implement cutting-edge research technologies. Under the umbrella of the ISC, five core facilities
(three established and two new) will provide robust Core-facility support that will benefit of all MS investigators
and provide a mechanism for Core facility directors to build strong interactions with investigators across
various disciplines in the state. In the proposed project period, as part of enhancing current infrastructure, ICS
will implement new high-throughput sequencing methods, such as single cell RNA sequencing, spatial
transcriptomics, metabolomics, development of a new and innovative capability involving CRISPR/Cas9 gene-
editing technology, along with new bioenergetic cellular assays to allow researchers a complete tool kit to
interrogate gene function and biological mechanisms. The following aims were developed to accomplish the
mission of ISC and to further the MS INBRE program: 1) to provide consultation, technical expertise on cutting-
edge multiomics, gene-editing, bioenergetic assays, and imaging research services to MS INBRE
investigators; 2) to provide education and training opportunities for students and faculty in the aforementioned
technologies; and 3) to seek continuous improvement in existing assays, services, and enhance technological
capabilities through acquisition of new cutting-edge instrumentation that will assist in the sustainability of cores.
Synergistically, these objectives will cater to researcher needs, and together with the Data Science Core
(DSC), the ISC will provide an innovative, state-of-the-art infrastructure to enhance and strengthen
investigation into the molecular underpinnings of biomedically important processes, bolster success in
extramural research funding, and collaboratively grow MS researcher capabilities.

Public health relevance
Project Narrative: The Mississippi INBRE Instrumentation and Services Core provides essential research infrastructure in the form of advanced instrumentation and also expertise. The capabilities offered through this Core are essential for the completeness of biomedical research in Mississippi. This will be accomplished by 1) providing access to instruments and expertise, 2) educate researchers and students in cutting-edge approaches, and 3) maintaining the competitive edge of Core services.